Synaptic changes in the medial prefrontal cortex in the development of compulsive alcohol drinking

The ability to inhibit drinking is a significant challenge for recovering alcoholics, especially in the presence of alcohol‐
associated cues. Repeated alcohol exposure induces neuroadaptations that persist beyond acute withdrawal, and which
increase alcohol's incentive salience, leading to escalation of alcohol intake and aversion‐resistant alcohol seeking. Alcohol
use also causes deficits in cognitive functions associated with the medial prefrontal cortex (mPFC), which further fuel
compulsive drinking and relapse. In rodents, alcohol seeking activates specialized networks within the ventral (infralimbic,
IL) and prelimbic (PL) regions of the mPFC, which play largely opposite roles in the control of relapse behavior. While
activation of the PL drives reinstatement, neurons in the IL facilitate extinction learning and inhibit drug‐seeking through
their projections to the Nucleus Accumbens shell, as well as the basolateral amygdala (BLA). However, there is a critical
gap in the knowledge about the synaptic mechanisms that drive maladaptive plasticity in these circuits during the
transition from controlled to compulsive alcohol‐seeking. Experiments in the parent grant application will provide a better
understanding of network‐specific mechanisms through which chronic alcohol exposure and withdrawal affect executive
cognitive functions of the mPFC and diminish inhibitory control over goal‐directed behavior. The objectives of this current
proposal, which is submitted in response to opportunity “Research Supplement to Promote Diversity in Health‐Related
Research (PA‐21‐071)”, are: First, to promote diversity in health‐related research by training Ms. Skylar Mendez, a PhD
student from a background underrepresented in bio‐medical sciences, and second, to enhance a basic science aspect of
the parent application by testing the central hypothesis that withdrawal‐activated neurons in the mPFC and the BLA are
also responsible for negative affective states that emerge after prolonged alcohol exposure and withdrawal. Aim 1 will
serve to train the candidate in behavioral measures of negative affect (specifically the Elevated Plus Maze, the Marble
Burying Task, and the Novelty Suppressed Feeding Task) and to validate these measures in chronically EtOH‐exposed and
withdrawn mice. In Aim 2 we will use Targeted Recombination in Active Populations (TRAP2) with Fos2AiCreER mice to
express halorhodopsin selectively in withdrawal‐activated neurons in the IL and PL, respectively. Neurons TRAPed in this
manner following either extended access to alcohol or under post‐dependent conditions will then be inhibited during tests
of negative affect (as described in Aim 1) to determine the contribution of these neurons to withdrawal‐induced negative
affective states. In Aim 3 we will similarly express halorhodopsin in TRAPed neurons in the BLA to test whether optogenetic
silencing of withdrawal‐activated afferents from the BLA to the mPFC can reverse alcohol‐induced measures of negative
affect. Taken together, these studies will provide important novel information about alcohol‐induced changes in networks
of the mPFC and BLA that contribute to negative affect and cue‐induced reinstatement. This project will promote diversity
in health‐related research, provide outstanding training opportunities in a multi‐level research training and career
development program, and it will enhance the parent grant by determining whether specific withdrawal‐activated
networks in the mPFC and BLA negative affect that contributes to relapse.

Public health relevance
PROJECT NARRATIVE: The experiments in this project will use an animal model of alcohol self‐administration to study maladaptive changes in cortico‐limbic networks that occur in the transition from goal‐directed to compulsive alcohol drinking and what effect that has on negative affective states (stress, anxiety). Understanding the development of these changes is important as they are likely to contribute to cognitive deficits and impact the ability of the prefrontal cortex to regulate drug‐seeking behavior.